Association of Peripheral Nerve Blocks with Postoperative Outcomes and Readmissions in Older Adults Undergoing Hip Fracture Surgery

PROJECT SUMMARY
Hip fractures in older adults represent a critical healthcare challenge, with one-year mortality rates
exceeding 20% despite advancements in surgical and anesthesia techniques. The choice of anesthesia for hip
fracture surgery may significantly influence postoperative outcomes and complication risks, but the extent and
nature of this association remain unclear. Traditionally, general and neuraxial anesthesia have been the
primary approaches for hip fracture surgeries. However, recent studies comparing the effectiveness of these
methods have yielded mixed results. As the debate continues, peripheral nerve blocks (PNBs) have emerged
as a promising adjunct to these traditional anesthetic techniques. PNBs have shown benefits in reducing pain
and opioid consumption, with some studies suggesting they may also lower morbidity and mortality rates.
Despite these promising findings, robust evidence on the long-term benefits of PNBs in hip fracture patients
beyond acute pain management is still lacking.
The objective of this proposal is to evaluate the association of peripheral nerve blocks (PNBs) on
postoperative outcomes in older adults undergoing hip fracture surgery. This will be accomplished through the
following aims: 1) Evaluate the association between peripheral nerve block use and in-hospital postoperative
outcomes in older adults undergoing hip fracture surgery; 2) Evaluate the impact of peripheral nerve block use
on 90-day hospital readmission rates among older adults following hip fracture surgery; and 3) Identify the
differential effects of peripheral nerve block on postoperative outcomes across specific subgroups of older
adults undergoing hip fracture surgery.
Leveraging the Premier Healthcare Database, which captures 20-25% of annual U.S. inpatient
discharges, we will conduct a large-scale retrospective cohort study focusing on patients aged 65 and older
who underwent surgical management of hip fractures. Statistical techniques to minimize selection bias, such
as propensity score matching, will be used to analyze a composite outcome of myocardial infarction, stroke,
and all-cause mortality, as well as hospital readmission rates. By addressing critical knowledge gaps in the
field, this study aims to provide further evidence on the potential benefits of PNBs in hip fracture surgery for
older adults.

Public health relevance
Project Narrative Hip fractures in older adults pose a critical healthcare challenge with high morbidity and mortality rates. This study investigates the association between peripheral nerve blocks and clinical outcomes in patients aged 65 and older undergoing hip fracture surgery. By examining outcomes beyond pain management, we aim to test anesthetic approaches that minimize complications and enhance evidence-based practices in geriatric orthopedic surgery.